Research Education

RESEARCH EDUCATION COMPONENT SUMMARY/ ABSTRACT
The overarching goal of the Research Education Component (REC) of the Shiley-Marcos Alzheimer’s
Disease Research Center (ADRC) at UC San Diego is to support the research education and mentoring of
outstanding junior-level scientists (defined as advanced postdoctoral fellows and assistant professors) to
advance our understanding of the complex and heterogenous nature of Alzheimer’s disease and related
dementias (ADRD). To realize this goal the Shiley-Marcos ADRC REC (1) has developed a detailed
recruitment plan to recruit a diverse cadre of outstanding trainees to the program each year, (2) will provide a
solid foundational platform to prepare this diverse research workforce with transdisciplinary expertise and
ability, and (3) engage our trainees and their mentors in the team science initiatives necessary to meet the
ambitious goals of the National Plan to address Alzheimer's Disease to prevent and treat ADRD by 2025.
The REC specific aims are to: 1) Develop the careers of advanced postdoctoral and junior faculty
researchers, who have demonstrated outstanding research potential and an interest in research focused on
understanding factors that affect etiology and outcomes in ADRD; and 2) Provide mentorship, education,
career development activities and a broad array of educational and infrastructural resources across the
multiple sites afforded by our rich academic and clinical settings (e.g., School of Medicine, main campus, VA,
and affiliated institutions such as the Salk Institute for Biological Studies) to enable our REC scientists to
enhance their expertise in ADRD research and research methods, successfully complete their research,
present and publish their work, and attain independent research and/or career development funding.
The Shiley-Marcos ADRC REC program will be directed by four Leaders from the School of Medicine and
main campuses at UC San Diego: Dr. Bondi (UCSD – Psychiatry; VA – Psychology / Neuropsychology),
McEvoy (UCSD - Radiology), Moore (UCSD – Medicine / Geriatrics) and Patrick (UCSD – Neurobiology /
Biological Sciences). The four Leaders have complementary scientific skills (e.g., basic vs. clinical science),
reside in multiple campus localities, and have collaborated to develop this program using the team science
model. The Program Faculty have been assembled with the goals of diversity with respect to their disciplines,
research and advanced mentoring skills, and affiliations. The REC Leaders will continuously and objectively
monitor the effectiveness of the training program, dynamically modifying the program based on feedback from
mentors, mentees, and the ADRC Executive Committee, to provide the highest quality training program
possible.